FASEB's Transcription, Chromatin and Epigenetics in Aging Conference

SUMMARY The goal of this FASEB meeting “Transcription, Chromatin and Epigenetics in Aging” is to cover the role new epigenetic mechanisms in the regulation of aging and in “rejuvenation” strategies for age-related diseases. Epigenetic mechanisms encompass post-translational modifications of chromatin and RNA as well as transcriptional regulation. This FASEB meeting will be unique in integrating the latest discoveries in epigenetics and their importance in aging and “rejuvenation” strategies for age-related diseases. There is a vital need for such a meeting. Exciting recent studies have revealed how organismal and cellular aging can be regulated by epigenetic mechanisms. The field of epigenetic is rapidly expanding, and the aging field needs to benefit from the latest and greatest discoveries in this area. Conversely, challenges and questions about the role of epigenetics in aging and age-related diseases abound, and it is critical for researchers in the chromatin and transcription fields to better grasp the implications of their work for health and disease. This FASEB meeting will discuss the most cutting-edge questions in field of chromatin, transcription, and epigenetics. A key topic will be the underlying molecular basis of epigenetic mechanisms. The question of how these mechanisms get dysregulated during normal aging and disease will also be discussed. The meeting will also cover new frontiers, including the exciting emerging field of three-dimensional chromatin structure and RNA epigenomics. The meeting will particularly focus on transformative epigenomic technologies at the single cell and single molecule levels and how they can be used to build and use “epigenetic clocks” in cells from individuals at different ages and to identify novel “rejuvenation” strategies for different age-related diseases. This meeting should foster exciting fundamental knowledge and information, new methodology and technical capabilities, and interdisciplinary collaborations. The meeting will also provide a uniquely interactive, diverse, and inclusive forum for trainees and new investigators in very different areas, highlighting their research through short talks, poster teasers and sessions and promoting several networking and meet-the-expert events.

Public health relevance
NARRATIVE This application seeks funding to support the participation of junior investigators at the 2021 FASEB science research conference on “Transcription, Chromatin and Epigenetics in Aging”, to be held in Catania (Sicily), Italy on September 19th – 24th, 2021. The main objective is to promote interdisciplinary discussion and collaboration among junior and senior physician-scientists and research scientists in fields related to chromatin, transcription, and epigenetics. Epigenetic mechanisms play central roles in cellular and organismal health. Dysregulation of epigenetic mechanisms is pivotal for aging and for several human diseases, notably age-related diseases such as cancer.